Exploiting the immunomodulatory effects of sulindac and novel non-COX inhibitory derivatives for cancer treatment

Project summary/abstract
Nonsteroidal anti-inflammatory drugs (NSAIDs) have cancer chemopreventive activity, but are not
recommended for long-term use because of toxicities resulting from cyclooxygenase (COX)
inhibition. However, sulindac and its congener, indomethacin (indo) inhibit the growth and induce
apoptosis of tumor cells in vitro and are potentially effective for treating malignant disease by
mechanisms that appear to be unrelated to COX inhibition. The Piazza lab has identified a novel
series of non-COX-inhibitory sulindac derivatives with potent tumor cell growth inhibitory activity
by targeting cGMP phosphodiesterase (PDE) isozymes, PDE5 and/or PDE10 to induce cGMP
signaling. MCI-030 is a prototypic non-COX-inhibitory sulindac derivative with selectivity for
PDE10 inhibition and strong in vitro and in vivo anti-tumor activity. Collaborative efforts from the
Zhou and Piazza laboratories discovered that sulindac, MCI-030, as well as a sulindac congener,
indomethacin (indo) are capable of inducing ER stress in tumor cells and can sensitize lymphoma
cells to T cells engineered to express CD19-targeting chimeric antigen receptors (CD19CAR).
These findings establish the premise of our hypothesis that it is feasible to design and develop
novel sulindac derivatives with potent tumor cell growth inhibitory and immunostimulatory
activities by targeting PDE5 and/or PDE10. The objective of our study is to define the molecular
and cellular mechanisms by which sulindac and its non-COX derivatives condition an
immunogenic tumor microenvironment. Specifically, we will determine how sulindac and non-
COX inhibitory derivatives induce cancer immunogenic cell death, mitigate Treg and MDSC-
mediated immunosuppression, and activate dendritic cells via effects on tumor cells involving ER
stress induction, and suppression of oncogenic -catenin, which we hypothesize are triggered by
PDE5/10 inhibition (aim 1). We will test the effectiveness of sulindac and non-COX inhibitory
derivatives that inhibit PDE5 and/or PDE10 in potentiating cancer immunotherapies including PD1
blockade and adoptive T cell therapy in multiple preclinical models (aim 2). Knowledge obtained
from Aim 1 and 2 will be integrated into a synthetic chemistry campaign to develop new sulindac
derivatives with improved antitumor activity by directly suppressing tumor cell growth and by
indirectly activating antitumor immunity, without the toxicities associated with COX inhibition (aim
3). Successful completion of the project will pave the way for developing novel sulindac
derivatives as immunomodulators for cancer treatment in the arena of cancer immunotherapies.

Public health relevance
Project Narrative Non-steroidal anti-inflammatory drugs (NSAIDs) such as sulindac can exert immunopotentiating effect by inhibiting the activities of cyclooxygenases (COX). However, long-term inhibition of COX can cause severe toxicities in some vital organs. This project will develop novel non-COX inhibitory sulindac derivatives and employ them as immunomodulators to augment the efficacy of cancer immunotherapies by targeting specific phosphodiesterase (PDE).